Mechanism of modulation of intestinal immune responses by dietary signals

Project Summary
The intestine serves both as a conduit for the uptake of food-derived nutrients and as a barrier that prevents
host invasion by microorganisms. This barrier function is important to maintain intestinal integrity and it is
promoted by immune cells, which can quickly respond to microbial presence in intestinal lumen coordinating
protective functions. Alterations in timing of food intake and diet composition have been associated with the
development of immune-mediated intestinal dysfunctions (e.g. irritable bowel syndrome). However, despite its
profound biological and clinical relevance, there is a major gap in our understanding of how intestinal immune
responses are modulated by food presence in the intestinal tract. The long-term goal of this proposal is to
determine how, during feeding, dietary-derived signals are sensed in the intestine and promote alterations in
intestinal immune responses. Recently, we uncovered a neuroimmune circuit that coordinates intestinal immune-
mediated barrier functions in response to food consumption. This neuroimmune circuit is formed by the
interaction of vasoactive intestinal peptide-producing enteric neurons (VIPens) and type 3 innate lymphoid cells
(ILC3s). VIPens are activated by the presence of food in the intestinal tract, they directly inhibit ILC3 functions.
Although VIPen-mediated inhibition of ILC3 during feeding reduces intestinal barrier functions, it also increases
efficiency of fat absorption from the diet (immune-nutritional trade-off). Importantly, in experimental mouse
models, perturbations in this neuroimmune circuit alters host resistance to enteropathogens and host-microbiota
interactions. We propose to study the mechanism of activation of VIPens by dietary signals as an entry point to
understand how feeding promotes alterations in intestinal immunity. A combination of cutting-edge technologies
to measure neuronal activation in vivo (genetically encoded calcium indicators and intravital imaging), manipulate
neuronal activity (chemogenetic tools and AAV-assisted CRISPR/Cas9-based genetic manipulation), dissect
molecular profiles of cellular circuits (monosynaptic viral tracing and single cell genomics), and control ingestion
of specific dietary signals (diet engineering), will allow us to acquire a mechanistic understanding of how food
consumption can affect intestinal immunity through neuroimmune circuits. The Specific Aims of this proposal
are: 1) to determine the nature of food-derived signals that, by triggering activation of VIPens, coordinate
intestinal immune-nutritional trade-offs, and 2) to dissect the cellular and molecular pathways of VIPens
activation by food-derived signals. These studies will provide the molecular underpinnings of how intestinal
immune responses are being modulated by food consumption, as well as provide new insights of the intestinal
mechanisms for sensing food-derived signals and orchestrating immune-nutritional trade-offs. These studies will
also advance the development of dietary-based therapies to boost immune-mediated barrier functions and the
mitigation of intestinal infectious and inflammatory diseases.

Public health relevance
Project Narrative The intestine exerts the important function of maximizing nutrient uptake from the diet ingested during feeding periods. Maintenance of intestinal health requires the precise regulation of local immune responses against microbes and dietary components. However, there is a major gap in our understanding of how dietary-derived signals affect intestinal immune responses during feeding. Gut neurons have emerged as important regulators of intestinal immune responses, since they interact with immune cells and are quickly activated by the presence of food in the intestine. Our studies of how diet modulates gut neurons that control intestinal immunity are expected to uncover dietary and neuronal therapeutic targets to gut disturbances associated with dysregulation in immune responses, namely intestinal infections and inflammatory bowel disease.